Integrating patient-specific clinical and biological factors towards individualizing utilization of proton and photon radiation therapy.

OVERALL - SUMMARY
This is a joint application for a program project grant by Massachusetts General Hospital and MD Anderson
Cancer Center. The progress we made in our most recent program projects (a P01 and a U19) has been criti-
cal to the clinical, physical, and biological aspects of proton therapy and its significance as an important cancer
treatment modality. The main achievements of the recently completed U19 (end date 8/31/20) were (1) the de-
velopment and activation of definitive esophagus, liver and glioma randomized proton vs. photon therapy trials
in cooperation with NRG, NCI and NCTN; (2) understanding and modeling the differences in response of nor-
mal tissues to highly disparate proton and photon dose distribution patterns; (3) understanding the complexities
of the biological effects of protons relative to photons; and (4) the development of advanced intensity modu-
lated proton therapy incorporating physical uncertainties and the variable biological effectiveness of protons.
Our research also revealed major gaps in the knowledge of the biological effects of protons, significant limita-
tions of the current population-based models of normal tissue and tumor response to protons vs. photons, and
uncertainty in the appropriateness of proton therapy in the face of heterogeneities in patient characteristics and
treatment techniques in unselected groups of patients. On the bright side, our research also discovered the
strong potential of proton therapy to reduce suppression of the immune system, which is commonly associated
with photon therapy and has been shown to lead to adverse outcomes. The overall goals of the proposed
P01 are (a) understanding relative clinical, biological and immunosuppressive effects of proton therapy vs.
photon therapy; (b) enhancing outcomes based on the physical, biological and immunological properties of
protons and photons; and (c) applying individualized (as opposed to population-based) approaches for the se-
lection of the optimum radiation modality for each patient and to enhance the potential for outcomes with the
use of radiation dose distributions tailored to the individual patient’s baseline and tumor characteristics. The
achievement of these goals will be carried out in three projects. Project 1: Understanding Normal Tissue Tox-
icity to Identify Patients Most Likely to Benefit from Proton vs. Photon Therapy; Project 2: Radiation-Induced
Lymphopenia (RIL): Understanding, Predictive Modeling and Developing Photon and Proton-Based Mitigation
Strategies; and Project 3: Investigating Enhanced Sensitivity of Tumors to Proton Beam Therapy: Mechanisms
and Biomarkers. The projects are highly integrated in that decisions regarding treatment modality selection,
treatment technique and optimization to maximally enhance the therapeutic ratio cannot be accomplished by
any one project alone. Such decisions must consider and balance normal tissue complications, tumor re-
sponse based on genotypic factors, and radiation-induced immunosuppression. The three projects will be sup-
ported by an Administrative Core and three resource cores: Core 1: Data Management and Computational
Support; Core 2: Translational Biospecimens and Imaging Biomarkers; and Core 3: Biostatistics.

Public health relevance
OVERALL – PROJECT NARRATIVE Advanced technologies in radiation therapy and the higher cost of proton therapy have engendered the need to accurately compare photon and proton radiation treatment modalities based on their clinical effectiveness to facilitate the improved selection of the optimum modality for cancer radiotherapy. As a follow up to our previous MD Anderson and Massachusetts General Hospital collaborative program projects, which explored the clinical applicability of proton therapy, in the proposed joint program project we will investigate the unique physical, biological and immunomodulatory properties of proton therapy vs. photon therapy and apply the knowledge thus gained to develop precision medicine techniques to identify the patients most likely to benefit from protons and optimize proton and photon therapy to maximize their effectiveness. This approach is a marked paradigm shift from the conventional assumption that improved dosimetry alone or population-based (as opposed to precision medicine) techniques will lead to better outcomes with protons in unselected patients and reframes the discussion for how patients should be assigned to a particular modality and their treatments optimized.